In vivo regulation of progenitor genome organization and cellular diversity

PROJECT SUMMARY
A fundamental question in brain development is how a small group of neural progenitors use a single genome
template to generate the vast diversity of neurons that underlie cognitive and motor function. It is generally
thought that the three dimensional packaging of the genome underlies cell type specific gene expression. Thus,
the physical organization of genes within nuclei must be specific to cell type and developmental stage. While
much progress has been made with high throughput approaches to uncovering genome-wide organizational
principles at different scales, what level of organization relates to gene function remains largely unknown. These
questions are particularly challenging for neural progenitors, which can produce distinct neuronal subtypes over
time. First, obtaining cell type and stage-specific genome profiling data that would allow one to detect meaningful
organizational features is technically difficult, and such features would be lost by averaging among bulk
heterogeneous cell populations. Second, there is a dearth of known trans-acting regulators of genome
organization that can be used for gain/loss of function studies to test their impact on genome organization. Third,
there are few experimental platforms in which to manipulate genome organization and validate their functional
significance on downstream gene expression in vivo. Here, we have established the Drosophila neuroblast (NB,
fly neural progenitors) system as an in vivo model to investigate how neural progenitor genome organization
impacts its ability to produce distinct transcription programs in the descendent neuronal progeny. We previously
showed that the hunchback (hb) gene, a key molecular signature of early-born neurons, relocates to the NB
nuclear periphery, where it becomes heritably silenced and refractory to activation in the postmitotic neurons.
Thus, changes in the genome organization of the NB progenitor directly regulates competence of the postmitotic
progeny to transcribe hb. We discovered 250bp cis-acting element with the hb gene that is necessary and
sufficient for hb gene relocation to the NB nuclear lamina, and mapped similar sequences genome-wide. Further,
we have identified a trans-acting factor that regulates hb gene relocation and NB competence via its liquid-like,
condensate forming properties. Here we will combine genetic and high throughput studies on purified, stage-
specific NBs to test how genome dynamics are regulated in neural progenitors in vivo. We will then test the
transcriptional consequence of genome reorganization of the NB on gene expression of the descendent neuron.
Together, our proposed studies will provide mechanistic insights into how genome organization is regulated in
neural progenitors and how genome dynamics contributes to neuronal diversification.

Public health relevance
PROJECT NARRATIVE The incredible diversity of neurons in our brains is generated from a small group of progenitors that produce each neuron type at the right time and place. It is thought that the folding and packaging of the genome determines cell type-specific gene expression, but how such organization is regulated in neural progenitors and how it changes over time to produce different neuron types is unknown. Using the fruit fly model system, results obtained in this grant will provide new insights into a fundamental question on how different neural identities are generated during brain development.